CORE--ADMINISTRATIVE AND DATA MANAGEMENT

Core A is the data management and administrative core unit for the Program Project. The purpose of this core is to provide integration and administrative support for the other two cores and the three research projects. In addition, this core will maintain fiscal accountability for the program project and facilitate data entry into the central data base. Core A, in collaboration with Core C (the Data Analysis Core), will manage the computer network linking all investigators for collecting, pooling, collating, analyzing and sharing data between projects.